Clinical trial readiness in X-linked dystonia parkinsonism: assessment of sensor-based and blood biomarkers for early detection and monitoring disease progression

PROJECT SUMMARY
Parkinsonism, the second most common movement disorder, affects over 900,000 Americans and its prevalence
is rising, while dystonia, the third most common, afflicts 250,000 Americans. X-linked dystonia parkinsonism
(XDP) is a rare neurogenetic movement disorder with a wide phenotypic spectrum ranging from a parkinsonism
indistinguishable from Parkinson's disease (PD), generalized dystonia, similar to DYT1 (a hereditary dystonia),
or combined dystonia and parkinsonism. Female XDP carriers are at risk for parkinsonism, given X-inactivation
and represents a possible genetic risk factor. As such, XDP serves as an excellent model of both dystonia and
parkinsonism, and insights can inform both phenotypes and mixed movement disorders, which are notoriously
challenging to assess. To provide adequate clinical trial endpoints, rater-independent, quantitative assessments
of motor function are urgently needed to identify early abnormalities which may predate overt clinical symptoms
and track disease progression, given the unreliability of rater-dependent clinical rating scales. This project will
provide Dr. Stephen with a skill set that will allow him to assess potential quantitative measures of disease
severity and progression in dystonia and parkinsonism using motion sensors and compare these measures with
proposed biochemical biomarkers, using machine learning to define optimal parameters. This project aims to
address three key knowledge gaps in dystonia and parkinsonism, using pure phenotypes (DYT1 and PD) and in
combination (XDP): Aim 1) to utilize technology-based evaluations as more sensitive and accurate measures of
dystonia in isolation (DYT1) vs. in combination with parkinsonism (XDP) compared to clinical scales; Aim 2) to
examine the accuracy of sensor-based monitoring of disease progression over 1 year in XDP, PD and DYT1
patients; and Aim 3) to analyze 2 proposed blood biomarkers (one specific to XDP, and neurofilament light chain,
a general marker of neurodegeneration) in XDP and combine these motor and blood markers, using machine
learning to predict disease phenotype/biotype and clinical course. This research complements the NINDS
objective of clinical trial readiness in rare neurological disorders, with a wider goal of better understanding these
common phenotypes in the context of a mixed movement disorder, using innovative technology and analysis
methods. The goal of this award is to prepare the candidate to become a fully independent investigator in the
quantitative assessment of dystonia, parkinsonism and other movement disorders, in the setting of expert
mentorship. The career development plan includes training goals: 1) learning transferrable motion analysis skills,
2) learning machine learning techniques to develop predictive models of motor behaviors and combining these
with blood biomarker data; and 3) an introduction to biomarker science and bioinformatics. Successful
completion of this project will put Dr. Stephen in a unique position to inform clinical trial readiness efforts in XDP,
relevant to other dystonia and to prepare for submission of a competitive R01 application focusing on quantitative
movement analysis and biofluid markers in genetic dystonia, parkinsonism and mixed movement disorders.

Public health relevance
PROJECT NARRATIVE Parkinsonism is the second most common movement disorder in the U.S, affecting over 900,000 Americans (projected to reach greater than 1.2 million by 2030) and dystonia (involving the development of abnormal posturing and uncomfortable twisting) is the third most common, afflicting more than 250,000 Americans: both disorders are a considerable source of morbidity and disability. X-linked dystonia parkinsonism (XDP), a rare neurogenetic movement disorder has a combination of both generalized dystonia and parkinsonism, with a wide phenotypic spectrum and may represent an independent genetic risk factor for the development of parkinsonism in female heterozygous carriers, such that studying XDP, while comparing to both disorders in isolation (DYT1, another hereditary dystonia, and Parkinson's disease, the archetypal parkinsonism) will inform both of these phenotypes, as well as the understanding and assessment of mixed movement disorders. This project will provide important contributions to the literature by providing: 1) new ways to quantify the neurological examination, which could identify rater-independent relevant clinical trial endpoints; and 2) potential motor and proposed blood markers, which, using machine learning, may be more accurate in combination, as a method to detect early disease, track progression and predict disease course, which will benefit not only XDP but other conditions with both of these motor phenotypes and neurogenetic disorders.